Using label-free Raman microscopy to predict therapeutic resistance of TNBC cells

This application is being submitted in response to the Notice of Special Interest (NOSI) identified as
NOT-CA-23-045.
Cellular heterogeneity has become critically important, limiting the effectiveness of therapeutics in
cancer treatment. The manifestations of cellular heterogeneity can be observed at the biochemical
(molecular composition and structure), morphological, and mechanical level, ultimately affecting cell
function. When considering non-invasive single-cell methods, the primary methods to assess
population biochemical heterogeneity are based on fluorescence activated cell sorting (FACS) of cell
surface markers. While extremely rapid, this method quantifies only specific molecules chosen by the
user; but what if the marker is unreliable? For example, studies have shown that enriching cells based
on FACS of CD44 surface markers only provides a population of cells in which 5% show stem-like
behavior. What about all the other potential molecular changes in lipids or nucleic acid chemistry that
were invisible in the FACS experiment, which might be informative as differentiating features in cells?
In this supplement request, we propose to develop a label-free, molecular imaging approach to
characterize cellular Raman fingerprints and train a convolutional neural network (CNN) to predict
therapeutic resistance in heterogenous populations. We will use high-speed, label-free nonlinear
Raman scattering, which captures a holistic molecular fingerprint of a cell by quantifying abundance of
metabolites, lipids, proteins, and nucleic acids and couple this data with CNN training and functional
drug screening. Building off our preliminary findings, a CNN will be developed and trained by culturing
different breast cancer subpopulations with increasing concentrations of doxorubicin and measuring
both live and dead cell Raman fingerprints (Aim 1). The CNN developed in Aim 1 will be tested for its
ability to predict subpopulation therapeutic susceptibility in co-cultures of the two subpopulations (Aim
2). This project offers not only a new take on phenotyping heterogeneous cancer cells, but it will also
be fully compatible with downstream functional or molecular testing such as tumor initiation or RNAseq
measurements.

Public health relevance
PROJECT NARRATIVE Heterogenous cell populations are a hallmark of all cancers and have severely limited the effectiveness of cell- based therapies. Existing tools to quantify single cell phenotypes probe biochemical or mechanical heterogeneity; however, they are imperfect due to limited ability to provide a holistic characterization of the molecular cellular fingerprints that ultimately determine cell function. Developing a method based on molecular phenotyping offers a new method to relate phenotypic heterogeneity with functional heterogeneity and help resolve the underpinnings of therapeutic resistance in cancer treatment.